Thiol Isomerases and Oxidant Stress in Thrombus Formation

Project Summary
Thiol isomerases (TIs) represent a previously unrecognized layer of regulation of thrombus formation. The role
of protein disulfide isomerase (PDI) family TIs in thrombosis has now been shown in animal studies using
genetically modified mice, antibodies that block TI activity, and small molecule antagonists of TIs. We have used
a PDI inhibitor prophylactically in a phase II study of patients with advanced malignancy to reduce cancer-
associated thrombosis. Yet despite the rapid progress in the therapeutic development of PDI antagonists, a
comprehensive explanation of how TIs promote clot formation has yet to emerge. TIs are fundamentally
endoplasmic reticulum (ER) redox sensors. Fueled by the oxidative environment of the ER, they use oxidants to
generate disulfides in nascent proteins. The studies described in this application will evaluate whether this
fundamental property of PDI family TIs powers their prothrombotic potential by translating vascular oxidants into
a thrombotic response. We will evaluate the hypothesis that oxidants generated in disease states promote
PDI sulfenylation and formation of oxidized PDI (oxPDI), which promotes thrombus formation through
disulfide formation in extracellular substrates. How the redox environment induces oxidative cysteine
modifications in PDI, which in turn control PDI function and enables PDI to oxidize thrombotic targets, will be
assessed using novel probes of cysteine modifications and chemical-proteomic approaches (Aim 1). These
experiments will define the cysteine modifications that PDI undergoes in the circulation and identify substrates
oxidized by oxPDI during platelet activation. Approaches described in Aim 2 will use structure-function studies
of PDI mutants and smFRET to define the molecular determinants of oxidant-induced disulfide formation in PDI.
PDI mutants deficient in oxidant-induced disulfide formation will be used in murine models of thrombus formation
to determine the role of oxidant-induced PDI disulfide formation in thrombosis. How oxPDI is released into the
extracellular environment to interact with the thrombotic machinery will be determined by evaluating the role of
the unfolded protein response (UPR) in promoting thrombus formation in an alveolus-on-chip model of pulmonary
inflammation (Aim 3). These studies will define specific UPR and TI pathways that activate coagulation and
determine how their activation causes a prothrombotic transformation of endothelium that results in
microvascular occlusion. The premise that inhibition of UPR receptors such as IRE1a, PERK, and ATF6 impairs
thrombus formation will be tested. Similarly, PDI and ERp46 will be evaluated as antithrombotic targets. This
program will test a new model by which to conceptualize the function of TIs in thrombus formation based on
understanding of determinants of redox environment and TI cysteine modifications. Validation of this model will
lead to the identification of new biomarkers and therapeutic targets for managing thrombotic disease in the
context of oxidant stress.

Public health relevance
Project Narrative Blood clotting that occurs in large arteries causes heart attacks and stroke, while clotting in small vessels can cause organ failure in the setting of infection. Current therapies to treat these thrombotic diseases are complicated by bleeding and recurrent clotting. We have identified a new layer of control of blood clotting mediated by thiol isomerases and will study the role of these enzymes in thrombus formation to identify better diagnostic and therapeutic approaches for the management of common, life-threatening clotting events.